NRSA Training Core

Addressing the shrinking clinician-scientist workforce depends on the early recruitment of
potential trainees along the clinical and translational training continuum. To address the future
workforce needs in the Midwest and across the nation, the Frontiers TL1 program will continue to
provide high-quality training in clinical and translational research to a dedicated group of trainees.
This region needs additional researchers who can make national contributions to translational
science while bringing new discoveries to the communities and patient groups that remain under-researched. Aim 1. Reinforce the clinician-scientist pipeline by recruiting a highly qualified,
dedicated, and multidisciplinary pool of TL1 predoctoral and postdoctoral trainees to build the
translational workforce. In Frontiers 1.0, we demonstrated success in recruiting pre-doctoral
clinical trainees. During Frontiers 2.0, we expanded the training tracks to include 4 post-doctoral
trainees per year. In Frontiers 3.0 we will focus on recruitment of trainees who bring perspectives
and experiences not widely reflected in clinical and translational research, and whose work
addresses communities with limited prior engagement in research. Aim 2. Enhance team science
in translational science workforce development through the utilization of experienced and skilled
multidisciplinary mentorship teams across Frontiers partners. We have expanded the list of
experienced and funded mentors from multiple programs across the Frontiers institutions who are
willing and capable of providing mentorship. These senior and mid-career mentors, along with
newly added junior mentors, already work in interdisciplinary, translational research teams and
will effectively demonstrate to our TL1 trainees the values of team science and collaborations
built between Frontiers partners. Aim 3. Build upon our existing novel and competency-based
clinical and translational research curricula. Our established, comprehensive, and successful
Frontiers Training program will provide TL1 trainees with critical competencies to successfully
conduct translational research. We will complement that degree program with a variety of
innovative short-term and non-degree training opportunities that address the needs of our
trainees and map to skills needed to launch independent research careers. Aim 4. Implement
more rigorous individualized evaluation methods integrated with trainee individualized
development plans to track success and enrich the training environment with efficiency and
precision. We will utilize a mixed methods evaluation plan that integrates the trainee
individualized development plan to track short- and long-term success of our trainees.